Symposium on Research in Child Language Disorders

ABSTRACT
This request is for five years of continuing support for the Symposium on Research in Child Language
Disorders (SRCLD) held annually at the Monona Terrace Convention Center in Madison, Wisconsin. This
symposium is sponsored by the Department of Communication Sciences and Disorders, University of
Wisconsin-Madison and by NIDCD/NICHD, as well as funds obtained through registration fees. SRCLD is
the only national conference devoted solely to research on child language disorders. Over the past 45 years
this meeting has achieved the distinction among child language researchers as a high-quality scientific
meeting which fosters the exchange of theoretical, experimental, and methodological advances among
professional researchers and doctoral students in training. Past programs have been uniformly of high
quality, featuring multiple invited plenary presentations by prominent researchers from the field of
communication sciences and disorders and related fields and a steady number of research papers submitted
for poster presentations or short oral presentations. The impact of the SRCLD conference has been
documented in several areas including its unique focus, program growth and quality, and the extent of
student participation in all aspects of the conference. NIH funds are requested to provide travel and per diem
for invited speakers, travel support for students, partial support for an administrative coordinator, and
website improvements and management. Progress since the last grant began in 2020 includes: 1) a vibrant
and diverse annual program comprised of 4 invited plenary talks, nine submitted short oral presentations,
and an average of 110 poster presentations; 2) support of a minimum of 20 students through NIH student
travel funds and private donations, with student travel award recipients consisting of 59% under-represented
minorities; 3) expansion of mentoring activities to include a formal round-table mentoring session; 4)
continued advances in the website which features an online poster attendance planner, expanded abstract
archives, and online evaluations; and 5) sustained international participation. Over the next five years we
intend to: 1) Highlight cutting edge and emerging topics in child language disorders through invited talks,
tutorials, submitted oral presentations, and posters; 2) Engage predoctoral and postdoctoral students in all
aspects of the conference, with an emphasis on inclusion of under-represented minority students; 3) Expand
mentoring and networking opportunities for early-career scholars, with a concerted effort to support scholars
from under-represented groups; and 4) Expand dissemination of the results of the conference through social
media.

Public health relevance
Project Narrative This proposal requests partial funding for continued support of the annual Symposium on Research in Child Language Disorders (SRCLD), a premier national meeting for researchers and students in training that is hosted by the Department of Communication Sciences and Disorders at the University of Wisconsin-Madison (https://srcld.wisc.edu/). Funds will be used to provide travel awards to allow students to participate in the conference, travel costs for invited plenary speakers, website management, and part-time salary support for a conference administrative coordinator.